The Impact of Vitamin D on mTOR Signaling, Seizures, and Motor Behavior in a Mouse Model of Hyperactive mTOR Induced Epilepsy and Ataxia

Project Summary / Abstract
Increased mammalian target of rapamycin (mTOR) signaling is a known cause of treatment resistant epilepsy.
Pathological mutations to negative regulators of mTOR lead to hyperactive mTOR signaling and have been
found in the forebrain and cerebellum of individuals with epilepsy. The cerebellum has recently been shown to
contribute to the development of epilepsy. However, research in hyperactive mTOR induced epilepsy has
almost exclusively been focused on the hypothalamus and forebrain structures. Individuals that develop
seizures associated with hyperactive mTOR in the cerebellum are often resistant to pharmacological
intervention and require invasive brain surgery. In severe cases, surgery can fail to control growth and must be
repeated. Thus novel treatments are critically needed. Preliminary data show supplemental vitamin D may
suppress epilepsy in a mouse model of hyperactive mTOR induced epilepsy and ataxia. This proposal aims to
determine whether vitamin D supplementation beginning during adolescence reduces seizures and co-
occurring motor impairments (Aim 1A), restores mTOR signaling in adulthood in a rodent model of hyperactive
mTOR induced epilepsy and ataxia (Aim 1B) and reverses cerebellar granule cell hypertrophy (Aim 1C). The
F99 phase of this fellowship will provide expertise and training in examining the molecular mechanisms
underlying genetic causes of neurological disorders and in the testing of novel mechanisms of pharmaceutical
therapies. The completion of the F99 phase will provide training that will serve as a springboard for the K00
phase. Baylor University possesses a strong molecular biosciences and imaging core, a dedicated graduate
writing center, and faculty and seminars devoted to professional training and teaching. The enclosed proposal
for the F99 and K00 phases outlines the training plan for a successful transition from a pre-doctoral trainee to
an independent investigator examining treatments for neurodevelopmental disorders.

Public health relevance
Project Narrative Individuals with epilepsy caused by hyperactive mTOR signaling and potentiated by a concurrent impairment in cerebellar function are often treatment resistant when treated with traditional anti-epileptic drugs. Treatments that target the underlying mechanisms have been found to reduce the occurrence of seizures but have been associated with severe to life-threatening side effects. In addition to providing the expertise and training for a career as tenured-track research faculty, here, the current proposal aims to determine whether vitamin D, a well-tolerable therapy with mTOR inhibiting effects, can serve as a novel or adjunctive therapy in the treatment of hyperactive mTOR induced epilepsies and co-morbid disorders.